Molecular Determinants and Behavioral Fingerprints of Schistosome Miracidia Host-Seeking

Schistosomiasis is a disease caused by chronic infections of human schistosomes, parasitic ﬂatworms
that are transmitted by aquatic snails. Schistosomes cause disease in over 250 million people but has
been designated as a Neglected Tropical Disease because of the outsized disease burden in
comparison to the investment given to it by the global health community. Schistosomiasis is controlled
primarily by mass drug administration (MDA) to people living in endemic areas. Though MDA has had
incredible success in reducing the burden of disease, many locations exist where schistosome
prevalence remains high despite repeated MDA with high coverage. In these cases, the stakeholders
are encouraged to implement snail control through chemical molluscicide treatment of local waters.
Chemical molluscicides are effective but can have harmful ecological consequences by eliminating
target snails and, at times, off-target invertebrates and plants. New strategies could be developed that
reduce the density of infected snails without reducing populations of snails themselves. Miracidia, the
aquatic snail-infective stage of schistosomes, utilize a variety of sensory modalities during host-seeking
(i.e., geosensation, photosensation, and chemosensation), resulting in accumulation near potential
snail hosts. Once a miracidium enters the active space of a snail – the area in which it can sense snail
chemical cues – it undergoes a distinct behavioral transition that results in contact with the snail. The
host-seeking and penetration behaviors have been qualitatively described by careful observation, but
quantitative models of these behaviors have yet to be generated, making them difﬁcult to
experimentally interrogate. Further, though a variety of circumstantial evidence exists that supports a
secreted glycosylated peptide as the primary snail cue sensed by miracidia, this has not been
conﬁrmed in vivo. This project will seek to quantitatively describe miracidia behaviors in the presence
and absence of snails and extract behavioral ﬁngerprints from high-resolution tracking data generated
from a unique, bespoke recording device with a large ﬁeld of view. Behavioral ﬁngerprints and an
optimized high-throughput experimental approach will set a foundation for screening of environmental
stimuli and small molecules for inhibitory effects on miracidia sensation of snail cues. In parallel, the
snail secreted peptide that is hypothesized to stimulate miracidia accumulation will be validated in vivo,
and a comparative approach using new genomic reference data from several schistosome snail hosts
will explore this critical host-parasite interaction among three 4 snail species and 2 schistosome
species. These comparisons will allow for the generation of a consensus sequence for the stimulatory
peptide, which could act as a scaffold for future optimization for activity on miracidia.

Public health relevance
PROJECT NARRATIVE Schistosomiasis is a devastating snail-transmitted parasitic disease of poverty that inﬂicts over 250 million people around the globe. Although host-seeking and infection of snails by larval parasites is a critical chokepoint for the parasite life cycle, the behavioral details and molecular determinants of this process are poorly described, limiting novel approaches for disease control strategies that could target the snail-infective stage. Using cutting-edge experimental technologies and advanced analytical tools, we will describe the snail cues and parasite behaviors that lead to snail infection, setting the stage for high-throughput screening regimens that discover new chemicals for parasite control.